Developing a sensor to monitor brain-to-gut communication

PROJECT SUMMARY
Dysregulation of neural control over gastrointestinal (GI) function is the principal cause of many digestive and
metabolic disorders. While significant strides have been made in uncovering the molecular and cellular
constituents of signals traveling from the gut to the brain, the reciprocal brain-to-gut communication remains
largely unknown. Researchers are severely limited by the lack of specialized tools to study GI function. In
response to this critical need, the overall objective in this proposal is to develop an implantable sensor enabling
precise examination of gastric motility in small animal models. Towards this goal, the proposed research
leverages recent breakthroughs in stretchable bio-electronics to address two specific aims: 1) Developing a
miniature implantable, wireless device for chronic monitoring of gastric motility in awake, freely moving mice; 2)
Employing optogenetic and microfluidic techniques to manipulate stomach activity and modulate motility
. This
application is poised to introduce groundbreaking methodologies for exploring the neural regulation of gastric
motility, and, in the long-term, provide therapeutic strategies to alleviate gastroparesis.

Public health relevance
PROJECT NARRATIVE The global prevalence of gastric motility disorders is 0.9%, yet their etiologies remain poorly understood. This proposed study seeks to develop an implantable wireless bioelectronic device, enabling precise monitoring and manipulation of gastric motility. Through this innovative approach, the study will uncover fundamental mechanisms driving these disorders and present potential avenues for new therapeutic strategies.